CHERISH (duCHennE caRdiomyopathy mItigation Sglt2 inHibitor)

PROJECT SUMMARY/ABSTRACT
Duchenne muscular dystrophy (DMD) is a devastating X-linked skeletal and cardiac myopathy resulting from a
defect in the gene coding for dystrophin. DMD myopathy leads to loss of ambulation, respiratory failure,
cardiomyopathy (CM), and premature death. Since the discovery of the DMD gene nearly three decades ago,
the field has been dominated by the expectation of a “cure”; this has not yet transpired. Gene therapies have
been approved but the cardiac effects remain unknown. Supportive care advances have decreased death from
respiratory failure but simultaneously unmasked the lethal and fully penetrant CM phenotype, which is now the
leading cause of death in DMD. We have documented that DMD CM progresses from normal imaging to diastolic
dysfunction with subtle strain abnormalities to manifest systolic dysfunction; these changes correspond
pathologically with myocardial inflammation and progressive increase in myocardial fibrosis and fibrofatty
infiltration. Guideline-directed medical therapy (GDMT) has become standard of care for patients with DMD, but
individual response to these therapies is suboptimal and often only serves to minimally delay the inevitable
progression to heart failure and early death. Sodium/glucose cotransporter-2 inhibitors (SGLT2i) have resulted
in mortality benefits in adult CM patients. The mechanism of this beneficial effect is unknown. Several factors
specific to DMD suggest that SGLT2i could have potential for DMD CM – 1) improved cardiac energetics and
metabolism (specifically, switch from carbohydrate towards fatty acids, ketone bodies, and amino acids
metabolism); 2) improved mitochondrial function and reduced oxidative stress; 3) anti-inflammatory; 4)
myocardial fibrosis inhibition; 5) reduction in sarcoplasmic calcium leak; 6) improved sympathetic overdrive. Our
prior work, funded by the NIH/NHLBI and the FDA, has created the DMD Cardiovascular Care Consortium
(DMDCCC), a multi-center consortium of 9 institutions following over 1350 DMD patients. The primary goal of
the DMDCCC is to discover surrogate outcome measures of CM for use in clinical trials and to leverage the
DMDCCC infrastructure for future clinical trials for DMD CM. The central hypothesis of this proposal is that
SGLT2 inhibition is safe and well-tolerated in DMD patients with early CM. Aim 1 will define the SGLT2i
pharmacokinetic (PK) profile in pediatric DMD patients. Aim 2 will determine the safety and tolerability of SGLT2i
in younger DMD patients with early CM. Aim 3 will evaluate the clinical efficacy and blood biomarker alterations
as a result of SGLT2i therapy in DMD, with a goal of informing future, larger efficacy studies. This study performs
a critical evaluation of the pharmacokinetics, safety, and tolerability of SGLT2i in DMD. The potential of SGLT2i’s
in DMD is immense, but a more complete evaluation must be performed before equipoise is lost.

Public health relevance
NARRATIVE Dystrophin associated heart dysfunction (CM) is a leading cause of death in patients with Duchenne Muscular Dystrophy (DMD); guideline-directed medical therapy has become standard of care for patients with DMD, but individual response to these therapies is suboptimal and often only serves to minimally delay the inevitable progression to heart failure and early death. Several factors specific to DMD suggest that sodium/glucose cotransporter-2 inhibitors (SGLT2i) could lead to significant improvements in DMD CM. The central objectives of this proposal are to utilize the Federally funded DMD Cardiovascular Care Consortium (DMDCCC), a multi- center consortium of 9 institutions following over 1350 DMD patients, to define the optimal dosing of SGLT2i in pediatric patients, determine the safety and tolerability of SGLT2 inhibition in DMD, and collect preliminary data on SGLT2i effectiveness for a future definitive clinical trial.